Channel Block and Gating of NMDA Receptors

The proposed research concerns N-methyl-D-aspartate receptors (NMDARs), brain proteins that are
activated by the neurotransmitter glutamate and mediate communication between neurons. NMDARs are
expressed by nearly every neuron in mammalian brains, and are required for normal brain function. NMDARs
also are involved in many human disorders including Alzheimer's disease, schizophrenia, and cell death
following stroke. There are several important drugs in common clinical use that act by binding to NMDARs, and
there is optimism that new, more effective NMDAR-targeted drugs can be developed. Most clinically useful drugs
that bind to NMDARs act as channel blockers, compounds that block current flow though the ion channel formed
by NMDARs. The mechanisms by which channel blockers interact with NMDARs are not fully understood. In the
proposed research we will examine a previously unknown path by which NMDAR channel blockers can access
the channel: by entering the plasma membrane, and then transiting from the membrane into the ion channel.
We will combine multiple approaches to uncover the characteristics and implications of channel blocker
transit from membrane to channel. We will use electrophysiological approaches to record NMDAR activity from
cells modified to express specific NMDAR subtypes, and will examine the properties of several channel blockers
used clinically or as research tools. Similar approaches will be used to study channel block of native NMDARs
in cultured neurons. We will use computational techniques in two ways: to model the mechanism by which
blockers associate with NMDAR channels, and to create models of NMDAR structure to predict the likely path
taken by channel blockers as they transit from membrane to channel. We then will test predictions of our
structural models using molecular biological techniques to change the chemical makeup of NMDARs, followed
by electrophysiological recording of resulting changes in channel blocker actions. Finally, we will use newly
synthesized channel blocking compounds to help critically test our hypotheses, and to explore how the structure
of channel blockers affects their interaction with NMDARs.
The implications of the proposed research will be broad. We will reveal the basic properties of a newly
discovered pharmacological mechanism by which an important class of inhibitors can interact with NMDARs.
Understanding of this new mechanism of NMDAR inhibition is likely to provide insights into how other types of
drugs interact with NMDARs, and into mechanisms that underlie modulation of voltage-gated channels. We will
develop structural models of NMDARs of broad utility. We will use our structural models to predict the path by
which drugs transit from membrane to channel and test our predictions experimentally. We will provide new
information about the inhibitory mechanisms of both well-known and newly synthesized NMDAR channel
blockers. We believe the knowledge gained from the proposed research will enable future design and synthesis
of improved drugs to treat the many disorders in which NMDARs are implicated.

Public health relevance
In the proposed research we will examine the properties and implications of a newly discovered mechanism by which clinically useful drugs can inhibit proteins essential for communication between brain neurons. The research will provide fundamental knowledge about compounds used to study nervous system function, compounds used to treat brain disease, and newly synthesized compounds. The proposed research will enable future design and synthesis of improved drugs to treat many nervous system disorders.